Progranulin Prosaposin and Lipid Biology in FTD

PROJECT SUMMARY
Loss-of-function mutations in the progranulin gene (Pgrn haploinsufficiency) cause genetic forms of FTLD with
TDP-43 inclusions. The PGRN protein and its bioactive cleavage fragments, the “granulins,” directly modulate
activity of the lysosomal protease cathepsin D (CTSD). PGRN traffics to the lysosome as a heterodimer with
prosaposin (PSAP). PSAP regulates the levels of sphingolipids, an important class of lipids with roles in intra-
cellular signaling, membrane trafficking and apoptosis. The specific effects of Pgrn haploinsufficiency on prote-
ase biology, sphingolipid metabolism and how PGRN and PSAP coordinately regulate protein and lipid home-
ostasis remain largely unaddressed. We aim to fill these major gaps in knowledge by delineating the complex,
downstream effects of PGRN and its cleavage products on lysosomal function. Our long-term goal is to under-
stand how aging and disease-associated lysosomal dysfunction promote neurodegenerative disease. In this
application, our overall objective is to determine how Pgrn haploinsufficiency impacts downstream processes
such as protease and sphingolipidase activity, TDP-43 and sphingolipid breakdown, and overall protein and
lipid homeostasis. Our central hypothesis is that Pgrn haploinsufficiency, via modulation of CTSD activity, con-
fers a “double hit” on protein and lipid metabolism, which impairs both TDP-43 and sphingolipid degradation,
ultimately leading to negative downstream consequences on lysosomal function and cellular health. The ra-
tionale for our work is that by understanding how PGRN, PSAP and their cleavage products regulate protein
and lipid metabolism, we will gain key insights into the mechanisms of neurodegenerative disease pathophysi-
ology. Thus, we propose the following specific aims: 1) Determine how PGRN and its cleavage products affect
CTSD-mediated TDP-43 breakdown and protein homeostasis; 2) Understand the impact that PGRN and its
cleavage products play on saposin production, sphingolipid levels and lipid homeostasis; 3) Interrogate the ef-
fects of Pgrn haploinsufficiency on lysosomal protease and lipidase pathways in humanized models. Upon
successful completion of the proposed research, we will have gained understanding of how PGRN impacts
downstream lysosomal processes such as protease and sphingolipidase activity, TDP-43 and sphingolipid
breakdown, and overall protein and lipid homeostasis. This contribution is significant because it will lead to a
comprehensive understanding of the complex, age- and disease-associated events associated with Pgrn hap-
loinsufficiency. This will further translate into better, more rationally targeted approaches to therapy in FTLD-
Pgrn and allow better understanding of the basic biology of the lysosome, how proteases and sphingolipidases
can be coordinately regulated and how dysfunctional protein and lipid metabolism contribute to FTLD patho-
genesis.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because, as our population ages, the financial and societal burden of neurodegenerative diseases will greatly expand over the coming decades. This proposal seeks to understand the pathobiology of FTLD-Pgrn, which will have several positive impacts, including understanding of potential negative consequence of progranulin replacement strategies and identification of novel targets for drug therapy in frontotemporal dementia and Alzheimer Disease. The proposed research is relevant to the NIH's mission of extending healthy life and reducing the burdens of illnesses like neurodegeneration, since its findings can be rapidly translated to mammalian systems.